Admin Supp: Investigating the molecular mechanism of mitochondrial tethering

Project Summary
We are interested in the dynamic interplay between the intracellular distribution of mitochondria and cellular
function. Mitochondria are important not only for cellular energy production but also play critical roles in cell cycle
progression, differentiation, immune responses, lipid and calcium homeostasis, and apoptotic cell death. These
diverse roles are intimately connected to mitochondrial shape and cellular position. Thus, it is not surprising
aberrant mitochondrial architecture has been implicated in an ever-increasing number of diseases. It is well
appreciated that mitochondrial division, fusion, and motility all contribute to the overall distribution of mitochondria
within a cell. However, the critical contributions of actively tethering the organelle to specific cellular sites and
structures, including other organelles, are becoming increasingly evident. While tethering plays a critical role in
mitochondrial positioning, interorganelle contact, and, consequently, cellular function in cells from yeast to
neurons, the molecular mechanisms and regulation are poorly understood. In the aims of this grant, we will
address this deficit by using a mitochondria-ER-cortex tether in yeast as a model to understand the mechanism
and regulation of mitochondrial tethers and the multifunctional mitochondrial membrane contact sites they create.
The proposed work will address the exciting and unexpected impacts mitochondrial tethers have on cellular
organization and function. The goals are to uncover fundamental mechanisms used by mitochondrial tethers to
position mitochondria and form interorganelle contacts and elucidate the functional and physiological
consequences of these activities. In doing so, this work will provide insight into novel therapeutic strategies for
a range of human disease conditions in which the manipulation of the position and the contacts made by
mitochondria can be used to positively influence cellular health and homeostasis. The requested supplement is
for the purchase of an MSM 400 Dissecting Microscope. The system is critical to support experiments that directly
impact and address the goals put forth for this project. By acquiring the MSM 400 Dissecting Microscope, an
essential but soon to be non-functional tetrad dissection microscope will be replaced and new techniques directly
relevant to the project will be feasible.

Public health relevance
Project Narrative The cellular position of mitochondria is intimately connected to both mitochondrial and cellular function. Central to mitochondrial positioning are molecular tethers, which exert spatial, temporal, and contextual control over the position of the organelle and anchor mitochondria to other organelles forming sites of contact that facilitate interorganelle communication. The goal of the proposed project is to understand the mechanism and regulation of mitochondrial tethers and the multifunctional interorganelle contact sites they create, providing insight into ways regulated mitochondrial tethering can be harnessed to influence mitochondrial function and overall cellular homeostasis and fitness.